Investigating the role of a novel RNA binding protein during dauer in C. elegans

MicroRNAs (miRNAs) are a conserved class of small, endogenous noncoding RNAs that regulate gene
expression post-transcriptionally. They play critical roles in essential biological processes, including animal
growth and development. Dysregulation of the miRNA pathway has been implicated in the pathogenesis of
various human diseases. miRNAs exert their function through the miRNA-induced silencing complex (miRISC),
which comprises the Argonaute protein (ALG-1 in C. elegans) and other protein cofactors. The composition of
miRISC—and thus its ability to degrade mRNA targets—varies based on tissue type and physiological
conditions. For example, somatic and germline miRISC recruit distinct cofactors, leading to different outcomes
for target mRNAs. miRISC composition also shifts dynamically in response to environmental stress or aging.
Under adverse environmental conditions, C. elegans enters an alternative, stress-resistant developmental stage
known as dauer. A key unanswered question in the field is how the miRNA pathway rapidly transitions from
regulating pro-developmental gene expression to stress-adaptive gene expression during this stage. Our
preliminary studies reveal two novel protein interactors of miRISC during dauer: the conserved RNA-binding
protein UNK-1 (Unkempt) and its binding partner, CRI-1 (Headcase). I hypothesize that UNK-1 and CRI-1 are
critical for stress adaptation in dauer by interacting with miRISC to promote the degradation of pro-developmental
gene targets. I will test this hypothesis in three specific aims: In Aim 1, I will characterize the interactions between
UNK-1, CRI-1, and miRISC, and determine whether they are mediated by direct protein-protein interactions or
indirectly through a shared set of mRNA targets. In Aim 2, I will identify the mRNA targets of UNK-1 and assess
their overlap with miRISC targets. Preliminary data indicate that UNK-1 expression is highly upregulated during
the dauer stage. In Aim 3, I will investigate the regulation of UNK-1 and CRI-1 expression during dauer and
evaluate their roles in stress adaptation. The conservation of UNK-1 and CRI-1 across species, including
humans, suggests that their role in miRISC regulation during stress may be evolutionarily preserved. This work
could provide insights into fundamental processes such as metabolism, aging, and cancer, offering broader
implications for understanding stress adaptation in complex organisms.

Public health relevance
While microRNAs (miRNAs) are known essential regulators of animal development, how miRNA-mediated gene silencing adapts to environmental stress, such as starvation, remains poorly understood. We have identified the conserved RNA-binding protein UNK-1 and its cofactor CRI-1 as novel interactors of the microRNA-induced silencing complex (miRISC) in the model organism C. elegans. Here, I will test the hypothesis that UNK-1 and CRI-1 promote miRISC-mediated silencing of pro-developmental genes under stress conditions, thereby enabling stress-adaptive gene expression programs to help animals respond effectively to environmental challenges.